Regulation of exosome release and its role in acute kidney injury.

Project Summary/Abstract
Acute kidney injury (AKI) is a condition that results in an abrupt decrease in renal function. AKI is associated
with morbidity, mortality, and health care costs. Unfortunately, the incidence rate of AKI in hospitalized patients
is still increasing. Furthermore, incomplete recovery from AKI leads to chronic kidney disease (CKD), and in
some cases, end-stage renal disease, which is also associated with significant morbidity, mortality, and cost. To
date, we lack methods to predict which patients will suffer long-term sequelae from AKI and treatments for AKI
except for supportive care.
Exosomes, nanometer-sized extracellular vesicles have been recognized as a fingerprint of the cellular states,
as well as a mode of intercellular communication in physiological and pathophysiological conditions. We recently
identified the role of exosomes in renal cell tubule growth, which is recapitulated and required for renal tubule
regrowth from damaged kidneys in AKI. Given the lack of clinical therapies and the critical links between AKI
and CKD, we will focus on whether exosomes released in AKI is an endogenous recovery mechanism, which
might be a tool to both treat AKI and prevent CKD. This proposal investigates the role of urinary exosome proteins
in recovery following AKI: Aim 1 will investigate how exosomes are produced, and their impact on in vitro healing
and tubule growth in the tubules-on-dish. We will manipulate the gene expression and/or mutation of regulatory
proteins in exosome biogenesis, in order determine the effects of the manipulation in renal cell tubule growth.
Aim 2 will investigate the role of controlled exosome release in in vivo mouse models of AKI. Using longitudinal
analyses of urinary exosomes released during AKI, viral delivery of exosome-incompetent target proteins, and
engineered exosome-mediated protein delivery, we will investigate the role of exosome-loaded proteins in renal
tubule regrowth. Signal transfer via exosomes within proximal tubules and proximal-to-distal tubules during AKI
will be determined as well. The results of these studies will determine if exosome release is an endogenous
recovery mechanism following AKI, and may generate therapeutic targets, as well as candidate prognostic
biomarkers for future studies in patients suffering from AKI.

Public health relevance
Project Narrative To date, there are no treatments for acute kidney injury (AKI), aside from supportive care, and no methods to predict which patients will recover from AKI during supportive care. Here, to address these challenges, we propose to study virus-sized extracellular vesicles (called exosomes) released during AKI and determine how exosome release is involved in kidney tubule regrowth following AKI. Successful completion of these studies will generate therapeutic targets, as well as candidate prognostic biomarkers for future studies in patients suffering from AKI.